Neuroimaging and Electrophysiology Facility (NIEF)

Project Summary:
The Neuroimaging and Electrophysiology Facility (NIEF) was established to increase the competitiveness
of scientists in Puerto Rico via the incorporation of microscopy and electrophysiology techniques in their
research projects. This aim was achieved by the establishment of two research cores, one at the Molecular
Science Research Center (MSRC) and another at the Institute of Neurobiology (INB), from the University
of Puerto Rico. Both facilities support a diversified group of investigators on the island. During phases 1
and 2 of COBRE, the NIEF acquired state-of-the-art instruments that are expensive and not accessible in
most laboratories, departments and/or institutions. Among the equipment obtained or supervised by the
NIEF are confocal, two-photon, and super resolution microscopes. Also available are electrophysiology
rigs for oocytes, cultured cells, brain slice, and anesthetized animals to monitor cell electrical activity. As
a result of the NIEF research infrastructure and expert technical personnel, 113 peer reviewed manuscripts
have been published, leading to 1,816 citations. Moreover, data obtained from the NIEF cores were
included in 84 grant proposals that were submitted to federal, state, and private agencies, and from those
submitted, 48 were funded. Furthermore, research performed in the NIEF permitted the innovation of new
technology by supporting investigators with the development of 7 patents. Finally, over 50 graduate
students from eight different departments and three main research institutions have benefitted from the
NIEF cores by being able to complete at least one of their theses aims and attain their academic degrees,
thus demonstrating the impact of the NIEF in the scientific community of Puerto Rico. These results
confirm the beneficial impact of the NIEF cores on the investigators in the island. Therefore, in this COBRE
phase 3 proposal, the goal is to maintain, strengthen, and support the NIEF cores by implementing three
aims: 1) to provide scientists in Puerto Rico with state-of-the-art instrumentation in microscopy and
electrophysiology, 2) to support the investigators in the island with expert staff that will help them with the
acquisition and analysis of the data from microscopy and electrophysiology techniques, and 3) to train
researchers in several technologies associated with these two approaches (microscopy and
electrophysiology) via seminars, workshop, and hands-on training. Thus, the facilities and services will
continue to help investigators use the most innovative electrophysiological and microscopy technology to
generate interdisciplinary projects to study biological and biophysical phenomena under the guidance of
experienced and excellent staff. Fulfillment of these aims will enable a transition of the NIEF to a
completely self-sustained facility beyond COBRE phase 3 and a role model for Puerto Rico and the
Caribbean.

Public health relevance
Project Narrative: The Neuroimaging and Electrophysiology Facility (NIEF) is a core with state-of-the-art instruments and experienced technical staff to support, guide and advice the scientific community in Puerto Rico. The main goal of this proposal is to maintain the NIEF services in microscopy or electrophysiological strategies and continue the positive impact of our investigators in terms of publications, grants submissions, grants funded, patents obtained and students who have completed their degrees by using the facilities. Excellent services and instruments in the NIEF at the Molecular Science Research Center and the Institute of Neurobiology, maximizes the impact of our cores to help a variety of investigators in the island and support the well-planned sustainability of the cores beyond COBRE-3.